Management and Administrative Core

The proposed Roybal Center will support a Management and Administrative (Admin) Core and a Pilot Core, The Administrative Core will help investigators find field sites for their research; provide general support and guidance; help investigators design studies using the Way to Health Platform; and continue to refine and improve mechanisms to enhance communication such as a dedicated website, listserv, works in progress seminars, and annual research retreats for Center faculty. The Specific Aims of the Management and Administrative Core are as follows: 1.) Provide central administrative support to plan, coordinate, and manage the Center's activities; 2.) Manage the Center Advisory Committee; 3.) Oversee the development, identification, review, and monitoring of pilot projects; 4.) Encourage and facilitate the development of networks among researchers and private and public sector entities to support translation activities 5.) Build strategic collaborations with health delivery systems, health plans, employers, and other external partners to increase the ability of Center, faculty to field test impactful ideas We will draw upon an experienced administrative staff and steering committee who have run our Roybal Center for the past five years, a core of 46 affiliated faculty members, and an extensive network of collaborating health care organizations. We will be guided by an External Advisory Board comprised of senior leadership of prominent organizations in health care including present or past CEOs of the National Business Group on Health (NBGH), the UPENN Health System, Equity Health (the Blackstone Group), Weight Watchers, and the Robert Wood Johnson Foundation (RWJF); the Chief Medical Officer of CVS Caremark; the global head of health care consulting for McKinsey; and a former CMS Administrator. As the program office for the RWJF pioneer program in behavioral economics and health and from planning and hosting 3 national conferences in behavioral economics and health we have developed a national network of faculty collaborators which we will continue to build upon as part of the proposed Roybal Center.

Public health relevance
RELEVANCE (See instructions): The Roybal Center will tackle major public health challenges such as obesity, sedentary lifestyles, a national shortage of organ donors, and medication non-adherence utilizing concepts and tools from behavioral economics and a network of social scientists and physicians centered at the University of Pennsylvania.